Targeting Endothelial Epsins to Ameliorate Myocardial Ischemia

PROJECT SUMMARY/ABSTRACT
Lack of oxygenation and nutrients that result from narrowed arteries and reduced blood flow debilitates the
normal function of the heart, leading to severe morbidity and early mortality worldwide. This devastating acute
medical episode is often seen in patients with obstructive plaques in their arteries. As a result, coronary artery
disease is the root cause of ischemic cardiovascular diseases such as myocardial infarction. Despite that a
healthy lifestyle and standard care may deter development of these diseases, risk factors such as obesity,
dyslipidemia, diabetes, and high blood pressure elevate the odds of recurrent myocardial infarction, leading to
heart failure, ischemic cardiomyopathy, or even death as well as a major financial burden to the society.
Reperfusion after acute myocardial infarction introduced by coronary angioplasty and direct stenting can cause
further damage to the injured heart. Unfortunately, the scarcity of novel molecular targets that stimulate natural
new blood vessel growth to restore blood flow and augment heart repair and regeneration creates a daunting
fight against this deleterious condition, for which there is currently no cure. The long-term goal of our research
is to discern molecular insight into endothelial regulation and heart regeneration in health and disease. In this
application, we aim to decipher molecular mechanisms behind the action of cardiac endothelial epsins in
regulating in myocardial ischemia. Epsins are a family of prominent endocytic adaptor proteins that were
originally discovered by the PI. We recently reported that targeting epsins in macrophages in atherosclerotic
plaques by nanoparticle-mediated delivery of epsin siRNAs prevents atheroma progression and promotes
atheroma regression, suggesting epsins as an emerging target for treating coronary artery disease in
preclinical models. Harnessing newly developed snRNA sequencing technologies, we made a potentially
groundbreaking discovery where the loss of cardiac endothelial epsins potentiates endothelial cell expansion
and precursor cell transition to fuel vascularization in neonatal hearts. We see heightened neovascularization,
bolstered cardiomyocyte proliferation in neonatal hearts of inducible endothelial-specific epsin 1 and 2 double
knockout (EC-iDKO) mice. Consistently, elevated revascularization, enhanced cardiac function and improved
heart repair and recovery from myocardial infarction in adult EC-iDKO mice. We posit that inhibition of cardiac
endothelial epsins fortifies angiocrine signals such as CXCL12-CXCR4 signaling, enable creation of a vast
endothelial cell reservoir to build vascular networks in the heart. Our central hypotheses are that epsins in the
cardiac endothelium suppress endothelial expansion, in part, by repressing CXCR4 signaling and hindering
heart regeneration and repair following myocardial ischemia. If successful, our proposed work will explore
uncharted territory, uncover original regulatory mechanisms, identify novel modulators, and inaugurate new
classes of restorative and regenerative therapies to treat deadly ischemic heart diseases and heart failure.

Public health relevance
PROJECT NARRATIVE The goal of our research is to provide molecular insights into endothelial regulation and heart regeneration and repair with the intention of uncovering next-generation therapeutic targets to increase blood vessel growth in injured heart following myocardial infarction. We discovered that loss of the epsin 1 and 2 endocytic adaptor proteins from the endothelium resulted in restoration of blood flow and contractile function in the ischemic heart through enhanced artery formation. Here, we will study the molecular mechanisms underpinning this phenomenon, which will allow us to discover novel targets that will propel development of effective treatment for ischemic heart diseases, a primary cause of mortality worldwide.